BLR&D Research Career Scientist Award Application

Dr. Dong is a nationally and internationally recognized investigator in the research field of kidney
injury and repair. His current work is focused on mitochondria, metabolism, autophagy, and
epigenetic regulation in kidney injury and repair under the disease conditions of renal ischemia-
reperfusion, diabetes, and cisplatin nephrotoxicity. As of July 1, 2019, Dr. Dong has published
256 research articles that have been cited for over 20,000 times with H-index of 66, attesting his
scientific contributions. Dr. Dong is currently the principal investigator on a VA Merit review award
and two NIH RO1 grants.
In the project of the VA Merit review award, Dr. Dong and colleagues will elucidate the
mechanism of renal fibrosis after ischemia-reperfusion injury. Specifically, they will determine the
role of renal tubular autophagy in kidney fibrosis after ischemia-reperfusion injury, delineate the
involvement of hypoxia-inducible factor 1 (HIF-1) in autophagy activation, and identify the key
profibrotic factors that are produced in renal tubules in an autophagy-dependent manner for
interstitial fibroblast activation. By elucidating tubular autophagy in renal fibrosis after ischemia-
reperfusion injury, this project may lead to the discovery of new therapeutic strategies.
In the project of NIH 5R01DK058831, Dr. Dong and colleagues propose to investigate the
mechanism underlying the heightened kidney injury sensitivity in diabetes. They will specifically
determine the role of p53 in miR-214 induction in diabetic kidneys, delineate microRNA-214 (miR-
214) repression of ULK1, and elucidate autophagy impairment as a key to injury sensitivity in
diabetic kidneys. Completion of this project will delineate a novel pathway of p53/miR- 214/ULK1
that leads to autophagy impairment and kidney injury sensitivity in diabetes. As a result, it may
identify miR-214 and autophagy as novel therapeutic targets for kidney injury in diabetic patients.
In the project of NIH 5R01DK087843, Dr. Dong and colleagues will investigate nephrotoxicity
induced by cisplatin, one of the most widely used cancer therapy drugs. Specifically, they will
elucidate mitophagy as a protective mechanism of autophagy in cisplatin-induced nephrotoxicity,
determine the autophagy-promoting role of p53, and analyze the effects of PKCδ inhibition in
autophagy-suppressed and non-suppressed mice. The research will not only gain insights into
autophagy protection and regulation in renal pathogenesis, but will also elucidate autophagy as
a mechanism of the renoprotective effect of PKCδ inhibition, suggesting novel therapeutic
strategies for kidney protection during chemotherapy in cancer patients.
In conclusion, Dr. Dong is an outstanding investigator who has made seminal contributions to
the research field of kidney injury and repair, which are highly relevant to veterans’ health. In the
ongoing projects funded by VA Merit and two NIH R01 grants, Dr. Dong will continue to make
important discoveries that may lead to novel therapies for kidney diseases for the improvement
of veterans’ health.

Public health relevance
In USA, over 300,000 cases of acute kidney injury (AKI) are diagnosed each year with a direct medical expense in billions of dollars. Aging population, mirrored by veterans, is highly susceptible to AKI. Moreover, AKI is an important factor for the development and progression of chronic kidney disease (CKD) that contributes significantly to cardiovascular disease and mortality in aging patients including veterans. Dr. Dong is an internationally recognized investigator who has made seminal contributions to the research field of kidney injury and repair, which are highly relevant to veterans’ health. His current research is supported by a VA Merit and two NIH R01 grants, and may lead to important discoveries and novel therapies for AKI and post-injury CKD for the improvement of veterans’ health. In addition, Dr. Dong contributes significantly to training/mentoring, collaboration, and service at both local and national VA levels.